CHIMERIC ANTI-CD4 WITHOUT CONCOMITANT DMARD THERAPY IN RHEUMATOID ARTHRITIS

The purpose of this study was to obtain placebo-controlled data on the clinical efficacy and safety of chimeric CD4 when administered daily for five consecutive days in patients with rheumatoid arthritis.